Interoceptive, Affective, and Cognitive Control Networks that Determine Self-Regulation and Reinforcement Learning of Smoking Decisions

PROJECT SUMMARY
Although quitting smoking offers significant health benefits for all age groups1, smoking cessation is notoriously
difficult to achieve2. Smokers commonly report that the greatest challenge in quitting is inhibiting and managing
the urge to smoke (i.e., self-regulation), which is often triggered by internal (interoception) or external
(exteroception) cues associated with nicotine (a primary reinforcer) through reinforcement learning3. While self-
regulation and reinforcement learning (RL) processes are crucial cognitive mechanisms that contribute to
successful smoking cessation outcomes, previous behavioral and neuroimaging studies have not provided
specific information about the computational and neurobiological bases of these key decision-making
processes that could be used to prevent self-control failures (e.g., a single puff after abstinence) at a particular
moment (e.g., a stressful situation) or condition accompanied by previously associated hyper cue-reactivity.
Using computational model-based multi-modal (EEG, fMRI) neuroimaging and novel custom-made EEG/MRI-
compatible e-cigarette smoking devices, we will investigate the neurocomputational mechanisms that
determine self-regulation and RL in smoking decisions at both short-term (trial-by-trial) and long-term (over one
year) levels. One hundred eighty e-cigarette or other electronic nicotine delivery systems (ENDS) users (early
adulthood; 21-35 years) who have thought about quitting smoking at least once in the past year will complete
two sessions. In the EEG session, participants, having abstained from smoking overnight, will make ‘real’
smoking choices about whether or not to take a puff of an e-cigarette under three conditions (emotional
distress, cognitive overload, and no stress). We expect that brain network interactions among interoception
(insula), affective/motivational (ventral striatum, vmPFC), and cognitive control (dlPFC) systems will predict
trial-by-trial self-control smoking decisions. In the fMRI session, participants will complete probabilistic RL and
extinction tasks using ‘real’ e-cigarette smoking and money as rewards. We hypothesize that brain responses
in the interoceptive (insula), affective/motivational (ventral striatum, vmPFC), and cognitive control (dlPFC)
regions will explain the dysregulation of RL and extinction with smoking rewards compared to money rewards.
In the one-year follow-up, we will systematically test whether participants’ smoking habit changes can be
predicted by our computational model parameters and EEG/fMRI susceptibility and resilience measures.
The knowledge gained from our study, which (1) predicts real smoking regulation decisions and (2) explains
the learning and extinction processes of cue-reactivity at both short-term and long-term levels, will have strong
ecological validity and provide valuable, transformative insights for developing novel interventions that may
prevent smoking lapses before they occur,
as often imagined in science fiction. Beyond smoking cessation
treatments, our project will also enhance scientific understanding of other self-control and hyper cue-reactivity-
related maladaptive lifestyle behaviors (e.g., obesity, alcohol or drug abuse) that increase the risk of cancer.

Public health relevance
PROJECT NARRATIVE Smokers commonly report that the most difficult challenge in quitting smoking is inhibiting and managing the urge to smoke, often triggered by internal or external cues associated with nicotine through reinforcement learning. Using computational model-based multi-modal (EEG, fMRI) neuroimaging techniques, we will investigate brain network interactions among interoceptive, affective, and cognitive control systems that determine self-regulation and reinforcement learning in smoking decisions at both short-term (trial-by-trial) and long-term (over one year) levels. By understanding why smokers fail to inhibit smoking urges at specific moments and why they experience dysregulation of reinforcement learning and extinction with nicotine rewards, it would be possible to provide more effective clinical interventions that reduce cancer and other health risks, thereby supporting the public health missions of the National Institute of Health.